Ligand-Dependent [alpha][beta]TCR Function

ABSTRACT – PROJECT 1
The αβ T lymphocyte ligand recognition process operates under nonequilibrium conditions, in contrast to that of
B cells and secreted antibodies. Physical force tunes ligand recognition sensitivity and specificity mediated by
αβT cell receptors (TCRs) during their immune surveillance to detect foreign peptides bound to major
histocompatibility molecules (pMHC) on diseased cells. Mechanistic elucidation requires deep understanding of
single molecule biophysics and structural biology in concert with T lymphocyte biology. The strategy of Project
1 is to pair single molecule and single cell measurements using optical tweezers (OT) in Aim 1 with functional
biological impact in Aim 2. We utilize a portfolio of influenza A virus (IAV)-specific CD8 clonotypes specific for
pMHC at abundant, intermediate and sparse array on antigen presenting cells (APCs). Our focus is on quality
of T cell performance in lymph node (LN) as well as lung along with characterization of primary and secondary
memory TCR features. Spatial transcriptomics in lung will assess single cell transcriptomes and paired TCR
sequencing, allowing TCR function in compliant and stiff tissue niches to be revealed and defining parameters
necessary to elicit digital T cells in distinct cellular environments. These highest quality CD8 T cells can detect
even a few copies of a ligand per cell, manifest long bond lifetimes, and undergo structural transitioning through
a mechanism that involves cycling between conformational states on a dynamic energy landscape. Mechanistic
details will be evaluated including force toggling required to drive transitioning, force magnitude comparison to
cell micromechanical properties, and molecular underpinnings of conformational transitions. A focus will be on
strengthening and weakening mutations that are informed by Project 3 molecular dynamics with the aspirational
goal to engineer digital performance into any TCR and hence regulate T cell recognition function in the future.
We shall further evolve our OT-based capabilities by merging single molecule single cell (SMSC) biophysical
and single cell activation requirement (SCAR) assays into the SM-SCAR assay where input profiles to a single
TCR can directly test requirements for activation. In contrast to digital cells, T cells entering primary memory in
LNs show profiles with relatively weak binding and analog performance (i.e., multiple pMHC copies per APC
required to activate T cells) in the context of high density pMHC array. Interestingly, differentiation into effector
and central memory subsets appear to be linked to Vα- or Vβ-pMHC binding bias, respectively, with signature
force bond lifetime profiles implying that selective load through TCR subunits impacts signaling and hence
resultant transcriptomes. Finally, we shall define the activation threshold and interrogate properties of primary
memory T cells, to investigate cross-reactivity through pMHC containing single point variations that may
engender heterotypic protection and to contrast primary memory with secondary memory recall responses.